m6A-suite: an informatics pipeline and resource for elucidating roles of m6A epitranscriptome in cancer

Project Summary
N6-methyl-adenosine (m6A) is the most abundant mRNA methylation in mammalian cells. Emerging evidence
has linked m6A with cancer phenotypes in many cancers, spurring a surge of research in studying m6A and
cancer biology. However, dysregulation of m6A effector writers, erasers, and readers and reprogramming of
m6A sites are poorly characterized. How different modes of m6A-regulation of gene expression mediate the
downstream cancer pathways and phenotypes is mostly missing. We have developed several widely used
informatics tools for m6A peak detection, differential m6A analysis, and functional predictions for m6A targets
from MeRIP-seq m6A profiling data. Using these tools, we worked together with cancer biology collaborators to
reveal reprogramed viral and host m6A epitranscriptome in cells infected by the oncogenic virus KSHV and
discovered a cross-talk between m6A writers, erasers, and readers to regulate cancer growth and progression.
However, the fast-moving m6A and cancer research poses many unmet informatics challenges. Among them,
the ability to accurately identify single-base m6A sites and predict key m6A regulatory mechanisms from
profiling data is seriously lacking. Also, a comprehensive database that catalogs and enables queries of where,
what, and how of m6A methylation and function in normal and cancer conditions is highly desirable. To address
challenges, we propose to develop m6A-Suite, an informatics toolbox, pipeline, and resources to facilitate the
mechanistic study of m6A in cancer. A key obstacle to developing tools in m6A-Suite is a lack of large, high-
quality training datasets. Toward this end, we have collected 1,113 human and 680 mouse MeRIP-seq
samples from cancer cell lines, tumors, and normal tissues and identified >4M m6A peaks. In parallel, we have
also collected 194,060 single-base m6A sites in 9 cell lines and 3 tissues. We propose to leverage this data to
construct the highly desirable training datasets. Using these datasets, we will develop efficient and accurate
tools for single-base m6A detection and quantification from MeRIP-seq and nanopore data (Aim 1), enable the
prediction of m6A-mediated RNA decay and splicing (Aim 2), and establish the comprehensive, queriable m6A-
KB knowledgbase to catalog these predictions in an extensive collection of public MeRIP-seq and nanopore
data in cancer and normal cells, and tissues in diverse conditions(Aim 3). We will systematically test and
evaluate these tools within this project and through many established and emerging collaborations inside and
outside the ITCR consortium. We will make the tools and data freely available to the research community and
constantly seek feedback from the collaborators and users for improvement. Given the emerging nature of
m6A and cancer research, the addition of these tools to the ITCR program will positively impact this important,
fast-growing, new area of cancer research.

Public health relevance
Project Narrative This project will develop the m6A-Suite informatics pipeline and the m6A-KB knowledgebase to enable global and unbiased delineation of the mechanistic roles of m6A epitranscriptome in cancer. m6A-Suite and m6A-KB address the unmet informatics needs for bridging the knowledge gaps in our understanding of m6A’s roles in cancer biology. They will have a transformative impact on m6A research and provide insights into m6A-based therapeutics.